Enhancing the Capacity and Capability of Human Food and Environmental Testing Laboratory at the Texas Department of State Health Services: Special Projects, Sample Collection

Project Summary Special Projects: Track 1 - Sample Collection The Foods and Drug Unit under the Consumer Protection Division (CPD) of the Texas Department of State Health Services (DSHS) has had maintained a partnership in support of cooperative agreements with the Laboratory Services Section (LSS). CPD has collected samples on behalf of LSS since the inception of the Federal Emergency Response Network (FERN)/ FDA Microbiology Cooperative Agreement (mCAP) in 2009. Currently, CPD supports LSS with sampling for the following cooperative agreements: FERN/FDA Microbiology Cooperative Agreement (mCAP) (RFA-FD-15-019) and the FDA Maintenance and Enhancement of ISO/IEC 17025 Accreditation Cooperative Agreement (RFA-FD-19-018). Through these cooperative grant opportunities, LSS and CPD have collected and analyzed an additional 15,000 samples since 2009 that would not have been tested without these grant opportunities in place. The purpose of this track is to assist laboratories in obtaining the samples needed to meet the goals specified in the human food testing tracks LSS is applying for under the new funding opportunity: (PAR-20-105) Laboratory Flexible Funding Model. Funds provided under this track will be utilized to cover costs CPD incurs while collecting samples for LSS to complete deliverables stated under human food tracks. Funding will be utilized to compensate CPD for collecting samples such as the supplies utilized during sample collection, paying for shipping costs, and paying for samples purchased at the manufacturer or retail location.